HYDROXYUREA ALONE &IN COMBINATION W/ DDI VS DDI IN PATIENTS WITH HIV INFECTION

The purpose of this short term study is to determine the safety and tolerability of hydroxyurea (HU) at various dose alone and in combination with didanosine (ddI).